A novel system and procedure for non-surgical placement of EEG electrodes in mice

Abstract
The development of new efficient tools for measuring electroencephalogram (EEG) in freely moving mice
is highly important in both academic and commercial research studies. EEG provides valuable
information on the impact of drugs on arousal and sleep architecture, and allows for the assessment of
their neuropharmacological characteristics in vivo, including central exposure and information on kinetics.
It is particularly useful for the development of novel medications in the animal models of
neurodegenerative diseases because these models are characterized by specific changes in the EEG
pattern that gradually develop over the course of the disease. Despite EEG measurements being highly
desirable in many research studies, their use is currently limited due to technical difficulties associated
with time-consuming surgeries required for implanting EEG electrodes (i.e., more than a half an hour per
one surgery) and a high cost of surgical materials. We recently filed a provisional patent application
describing a new system and procedure for the implantation of EEG electrodes in mice that can be
performed within a few minutes. This procedure is considered non-surgical because it is minimally
invasive and does not involve cutting. In this project, will enhance the key features of the system to
enable a larger set of research applications and start disseminating our products in research laboratories.
Our ultimate goal is to provide user-friendly tools for recording and analyzing EEG in freely moving mice
that will both benefit the welfare of research animals and allow neuroscientists completing research
projects faster and with a lower cost.

Public health relevance
PROJECT NARRATIVE The impetus of this proposal is the development of a new system that allows non-surgical placement of EEG electrodes in mice. Anticipated results from our easy-to-use system will allow for more consistent data due to reduced data artifacts and less stress induced on the mice, provide the ability for more normal activity patterns to be conducted by the mice, allow high-throughput studies, and improve the reliability and accuracy of drug generation.